Neuregulin-4: A Novel Therapy for Inflammatory Bowel Disease

ABSTRACT
Inflammatory Bowel Disease (IBD) is a collective name for Crohn’s Disease and Ulcerative Colitis (UC). Both
conditions manifest with a pathological inflammation of the bowel that causes breaks in mucosal integrity, frank
ulceration and the risk of more severe complications. While the etiology of IBD is complex and not fully
understood, the distinguishing hallmarks of IBD are dysregulation of normal immune function and impaired
epithelial repair. None of the currently available treatment modalities have a specific targeted effect to retain
mucosal integrity or to heal breaches in the gut mucosa. Moreover, most drugs in development are focused on
modifying the local inflammatory response and not on direct protection and repair of the intestinal epithelium.
Therefore, there is a high unmet medical need for a treatment modality that could both directly target gut barrier
protection to restore mucosal integrity, and ameliorate the abnormal inflammatory response. Avexegen
Therapeutics, Inc. is leveraging the biology of neuregulin-4 (NRG-4), a naturally occurring peptide found in
human breast milk, as a novel mucosal healing therapy. NRG-4’s physiological role is in the direct protection of
the intestinal epithelium, attenuation of inflammation and the preservation of Paneth cells that are critical for anti-
microbial defense and trophic support of intestinal stem cells. Our SBIR Phase 1 studies showed that systemic
NRG-4 is efficacious in the mouse DSS-induced colitis model, and demonstrated that oral NRG-4, while being
metabolized in the gut, dose-dependently reduces gut inflammation and showed a positive trend towards colon
protection. Based on our collective evidence, an orally-optimized NRG-4 can potentially be a superior treatment
for IBD or a desired complement to other treatment approaches. For our Phase 2 program, Avexegen proposes
the following aims: conduct SAR studies to identify an intestinally stable peptidic NRG-4 analog with improved
receptor potency and then demonstrate efficacy in the DSS mouse colitis model using intracecal administration
to bypass the stomach. Next, formulation development with a lead NRG-4 analog will be undertaken to generate
enteric-coated NRG-4-microcystalline cellulose (NRG-4-MCC) beads that are stable in acidic pH conditions of
the stomach and release NRG-4 under near-neutral pH conditions in the intestine. Finally, a dose-response
study with orally delivered NRG-4-MCC bead suspensions will be conducted to assess efficacy in the DSS
mouse colitis model; receptor engagement, NRG-4 analog’s presence in the colon, and little or no systemic
exposure will be demonstrated. Successful completion of the studies will provide an oral NRG-4 drug product
candidate for IND-enabling activities and a rich dataset for the pre-clinical and CMC data package for an IND
filing. In addition to IBD, this NRG-4 drug will be highly valuable for treating other inflammatory GI conditions
where the repair and retention of intestinal mucosal integrity are key treatment objectives.

Public health relevance
PROJECT NARRATIVE Inflammatory Bowel Disease (IBD) affects more than 3 million patients in the US, manifesting as a pathological inflammation of the bowel that causes breaks in mucosal gut integrity, ulceration and the risk of severe complications. Current treatment approaches have shortcomings. Neuregulin-4 (NRG-4) is a physiological factor that directly promotes healing of inflamed and damaged intestinal tissue, and therefore the restoration of mucosal integrity that is critical for disease remission. Avexegen seeks to develop an optimized NRG-4 analog as an oral mucosal healing drug to treat IBD.